A Randomized Trial to Optimize Skeletal Muscle while Reducing Adiposity in Veterans with HIV

The Department of Veterans Affairs is the largest single provider of medical care to people with HIV in the United
States. With the advances achieved in antiretroviral therapy (ART), Veterans with HIV now survive decades.
However, this success is tempered by the rising burden of obesity now affecting 78% of Veterans. Defects in
adipose tissue lipid storage and regulation are hallmarks of both treated HIV and obesity, which leads to a high
degree of ectopic fat infiltrating organs and tissues such as skeletal muscle. The condition of excess lipid within
and around muscle, termed myosteatosis, predisposes Veterans to physical function decline, frailty, disability,
and cardiometabolic diseases such as diabetes and cardiovascular disease. In our current Merit supported
cohort, we found that 36% of Veterans with treated HIV and obesity have “myosteatotic type obesity”. Further,
we found that high ectopic fat accumulation in muscle (quantified by CT imaging of skeletal muscle density) is
associated with reduced mitochondrial oxidative capacity, greater inflammation, and impaired muscle glucose
tolerance and insulin sensitivity. Hence the quality of muscle is just as important as the quantity of muscle.
However, this important phenomenon has received little attention, especially in Veterans with HIV. Indeed, the
need to target mobilizing and metabolizing skeletal muscle ectopic fat while preserving/increasing the total
amount of skeletal muscle is most often overlooked and represents a major research gap and unmet clinical
need. From our current Merit Award funded study, we have an established collaboration of experienced VA
researchers with expertise in HIV and immunology, human nutrition and metabolism, endocrinology, radiology
and imaging science, and muscle physiology. Based on our findings, we have designed a multipronged
integrated intervention that combines: 1) dietary replacement of saturated with unsaturated fats; 2) administration
of L-carnitine and omega-3 fatty acid supplementation; and 3) targeted resistance exercise training. This
evidence-based intervention is designed to: a) increase lipid flux by facilitating the transfer of long-chain fatty
acids into muscle mitochondria for β-oxidation; b) decrease muscle proteolysis; and c) lessen insulin resistance
and inflammation. Using a mixed 2x4 factorial design trial design in a cohort of 60 Veterans who have HIV and
obesity, this study will determine the main and interaction effects of the multi-pronged intervention on: skeletal
muscle density, mitochondrial oxidative capacity, and fatty acid oxidation (Aim 1); glucose tolerance, insulin
sensitivity, and inflammation (Aim 2); and cardiopulmonary exercise tolerance and physical function (Aim 3).
Obesity in Veterans with treated HIV is a heterogeneous condition. Our current Merit research shows
myosteatotic obesity is a distinct condition from visceral or steatotic or sarcopenic obesity, affected by different
clinical factors. Our findings to date provide the foundation for a novel evidence-based intervention that has the
potential for significant clinical impact on Veterans, including and beyond those with HIV. This proposal meets
VA-ORD priorities to improve health behaviors, focus on underserved Veterans, and provide precision care.

Public health relevance
The Department of Veterans Affairs is the largest provider of medical care to people with HIV in the U.S. While effective in extending survival in Veterans with HIV, the success of antiretroviral therapy (ART) is offset by the rising burden of obesity. Our data shows obesity in Veterans with HIV is a heterogeneous condition, with 36% having myosteatostic or myosteatostic + sarcopenic type obesity. The interaction of HIV, ART, and obesity, yield changes in adipose tissue function impairing ability to store energy, and thus, lipid infiltrates organs and skeletal muscle. Accumulation of this “ectopic” fat may be driven by mitochondrial dysfunction which promotes insulin resistance, risk for cardiometabolic disease, and loss of muscle physical function. This study will test co-administration of L-carnitine to promote oxidation of fatty acids, n-3 fatty acids to reduce muscle fat infiltration, and resistance exercise to promote muscle protein synthesis.